TOPMed WGS and Molecular Epidemiology Analyses for Cardiac Hypertrophy Phenotypes

PROJECT SUMMARY/ABSTRACT
Left ventricular hypertrophy (LVH) represents one of the most potent risk factors for cardiovascular disease
(CVD), including ischemic heart disease, chronic heart failure, and cardiovascular death. The risk of LVH is
determined in part by genetic factors and results from Genome-wide Association Studies (GWAS) and Whole
Exome Sequencing (WES) already identified some distinct variants and genes.
Recently, the NHLBI TOPMed program has been generating one of the largest Whole Genome Sequencing
(WGS) data sets. Our proposal builds on over 26,000 WGS samples from most of the large CV cohorts with
relevant echocardiographic structural phenotypes. We will utilize association results from these extensive
datasets as they will provide unprecedented insights into the genetics of LVH and associated phenotypes. The
next important challenge for complex disease genetics and genetic epidemiology will be to elucidate the role
and function of identified WGS genes. Functional studies fundamentally rely on relevant human disease
models, which capture genetic and genomic features and model the polygenic nature of complex disease
phenotypes. Human induced pluripotent stem cells (hiPSCs) provide a ‘human in a dish’ platform to study
genome function. For this application, we will focus on analyzing the effects of novel WGS gene variants for
LVH and associated structural cardiac phenotypes by using hiPSCs for functional molecular epidemiology and
network prioritization-based approaches.
We expand on our previous work and propose to functionally test and annotate a subset of significant WGS
association signals for selected candidate genes and variants using genome and gene editing in hiPSCs and
derived cardiomyocytes. Genes will be selected using on a prioritization-based approach to identify high impact
variants. We will also further refine and develop approaches for network-based expression data analyses.
Subsequently, we will use expression-based network concepts to describe cellular mechanisms and provide
functional annotations for specific WGS genes and variants. In combination, our molecular epidemiology
approach is an innovative method to the functional analysis of WGS association signals.

Public health relevance
PROJECT NARRATIVE The application will focus on functional analyses of genes and genetic variants which have been identified for Left Ventricular Hypertrophy using Whole Genome Sequencing. We proposed to use human induced pluripotent stem cells and derived cardiomyocytes to perform genome and gene variant editing. We will focus on network-based analyses to identify associated pathways to understand and dissect underlying disease mechanisms.